Training in Biotechnology: Emphasis in Protein Chemistry

The Washington State University Protein Biotechnology Program is an NIGMS-supported training program that prepares graduate students to translate fundamental scientific discoveries into biotechnological innovations. Our program includes 45 students and 45 faculty who represent five diverse graduate programs in four different colleges. This long-running collaboration offers interdisciplinary training to individual students and has resulted in strengthened curricular and physical connections between affiliated departments. As a supplement to home degree requirements, the Biotech program sponsors inter-departmental rotations, supported industrial internships, courses on research practice and biotechnological entrepreneurship, monthly student Forums, student-organized annual research symposia, and enhanced research mentoring. These activities provide Biotechnology Trainees and other Washington State University students unique opportunities for skill development and research career awareness. To further increase the ability of our faculty Trainers to contribute to this training program, we propose to add a monthly “Faculty Forum” that, without duplicating existing efforts, will synergize Trainee-advisor mentoring, build additional cohort unity, and enhance the effect of other training program activities? benefiting students and faculty. Faculty Forum curriculum will be comprised of three components: Entering Mentoring activities, cohort specific training, and engagements that connect faculty with each other, Trainees, and WSU resources. Evaluation will include use of the CIMER assessment platform, drawn on a proven program for evaluating Entering Mentoring implementations and mentoring climate. Biotech program facilitators will attend training to develop transferable, enduring facilitation capacity. Mentoring curriculum and facilitation expertise will be shared with other Washington State University entities; e.g., both the Provost’s office and the iPBS graduate umbrella want to add mentor training that will be informed by our trailblazing efforts. Program and outcomes will also be shared publicly via our website, NIGMS presentations, and (as warranted) publication. Grant funds will catalyze year one access to resources and activity and created capacities will be sustained by existing institutional supports and collaborations.

Public health relevance
Project Narrative from Parent Award Since its origin in 1976, the American biotechnology industry has grown into a mature sector of the economy, with 2016 revenues of over US$139.4 billion. Furthermore, biochemistry and biophysics is designated as a high growth industry by the U.S. Department of Labor with National Employment Data projected to increase by 11% from 2016 to 2026, faster than the average for all occupations. Our Biotechnology Training Program is designed to address the current and future needs of the growing biotechnology industry by providing interdisciplinary training in biotechnology with a major emphasis on the fundamentals and complexities of protein chemistry.